Neuronal Mechanisms of Copper Transport and Toxicity

How does copper exposure perturb neuronal cells leading to cell death? This application seeks to address this question by studying novel mechanisms that we discovered whose genetic defects confer susceptibility to or protect against metal toxicants. We propose that these copper homeostasis mechanisms are shared with pathways affected in common neurodegenerative disorders, such as Parkinson’s disease. Copper is an essential micronutrient but, in addition, copper is also a powerful neurotoxicant whose free levels in the cytoplasm must be tightly controlled. Here we focus on a genetic defect that renders cells susceptible to copper, Menkes disease, such that normal environmental copper becomes toxic to cells in culture. Menkes disease, is a progressive childhood neurodegeneration caused by mutations of the copper pump ATP7A. In this application, we present exciting data revealing novel mechanisms associated to Menkes copper toxicity which are shared with genetic forms of neurodegeneration. We postulate that copper toxicity is modulated by membrane traffic mechanisms controlling copper transporters expression and subcellular location, ubiquitination, and mitochondrial metabolism. This proposal will test this hypothesis in mice and Drosophila carrying mutations in pathways associated to ATP7A. Genetic defects in these ATP7A regulatory pathways also cause neurodegeneration. The completion of this proposal will open the door for clinical interventions to improve outcomes of neurological diseases where environmental factors participate in pathogenesis.

Public health relevance
This application seeks to understand neuronal copper toxicity focusing on Menkes disease, a genetic defect in the pump ATP7A. We propose that Menkes disease neurodegeneration mechanisms are shared with other genetic forms of neurodegeneration.